Elucidating mechanisms of therapy response in BRCA2 mutant prostate cancers

ABSTRACT
Prostate cancer is the most common non-skin malignancy in men and is projected to cause 34,500 deaths in
2022 in the United States alone. Sequencing studies of advanced lethal castrate resistant prostate cancer
(CRPC) have identified a high incidence (~13%) of pathogenic BRCA2 mutations. These findings have enabled
clinical trials and subsequent Food and Drug Administration (FDA) approval of the poly (ADP-ribose) polymerase
(PARP) inhibitors (PARPis) olaparib and rucaparib in advanced CRPC patients harboring a pathogenic BRCA2
mutations. Despite initial responses, therapy resistance to PARPis is common. However, the molecular
adaptations that occur in BRCA2 mutant CRPC in response to PARPi are poorly understood, due to a lack of
biologically and clinically relevant models. Our proposed studies leveraging two new patient-derived model
systems of pathogenic BRCA2 mutant CRPC will elucidate the biological mechanisms implicated in PARPi
therapy response and help address a critical clinical unmet need to prevent or overcome resistance to PARPis.
In this proposal, we will use two new models of pathogenic BRCA2 mutations in CRPC, including the 40511
cell line and matched PARPi-sensitive and resistant LTL-610 PDXs. Gene Set Enrichment Analysis (GSEA) and
Over-Representation Analysis (ORA) of RNA-sequencing data utilizing these novel models point to significant
upregulation in genes involved in Extracellular Matrix (ECM) modulation in response to both short and long term
PARPi therapy. In particular, the ECM associated gene SERPINE1, which encodes for the protein Plasminogen
Activator Inhibitor 1, (PAI-1) is the most significantly implicated gene after 72 hours of olaparib treatment via
GSEA leading edge analysis. Since PAI-1 canonically prevents ECM degradation, we then used Masson’s
Trichrome staining to evaluate the PARPi resistant LTL-610 PDX and found dramatically increased Type I
Collagen deposition compared to its PARPi sensitive parental line. Since stromal alterations are known to affect
cancer cell survival, we hypothesize that the induction of ECM genes like SERPINE1 by PARPis in BRCA2
mutant CRPC results in enhanced tumor stroma, and enables therapy resistance. Two specific aims are
proposed in this grant to study this hypothesis: in Aim 1, we will elucidate the role of SERPINE1 signaling in
ECM deposition in BRCA2 mutant CRPC in vitro, ex vivo, and in vivo. In Aim 2, we will investigate the mechanism
of transcriptional activation of SERPINE1 in BRCA2 mutant CRPC in response to PARPi. The results from these
studies will enable systematic approaches to modulate ECM alterations in response to PARPi in BRCA2 mutant
CRPCs.

Public health relevance
PROJECT NARRATIVE Poly (ADP-ribose) polymerase inhibitors (PARPis) were recently approved to treat advanced BRCA2 mutant prostate cancers, yet little is known about the molecular response of these tumors to this therapy. This proposal employs novel model systems of BRCA2 mutant prostate cancer to explore the molecular alterations that occur in response to PARPi therapy, with specific focus on extracellular matrix (ECM) pathways identified in preliminary results. The proposed studies will interrogate the impact of PARPi on ECM modulation and examine the contribution of the ECM gene SERPINE1, with the long-term goal of utilizing the knowledge gleaned to develop novel targeted therapies.